Genome Analysis Shared Resource

GENOME ANALYSIS SHARED RESOURCE PROJECT SUMMARY
The Genome Analysis Shared Resource (GEN) provides Mayo Clinic Cancer Center (MCCC) members
efficient, high-quality, cost-effective access to state-of-the-art genomics technologies for studying gene
structure and function. Since 2003, the GEN components have been working in a coordinated fashion to
provide technical expertise, instrumentation, and comprehensive support for nucleic acid sequencing, gene
expression profiling, and genotyping. Support for NextGen sequencing and gene expression regulation through
RNAi analysis were added in 2007. The services provided by the facility include deep sequencing studies of
RNA and DNA on Illumina NovaSeq, HiSeq and MiSeq instruments, and Pacific Biosciences Single Molecule
Real Time Sequencing on the new Sequel platform. In addition, we offer full-service genotyping and gene
transcript analysis using Affymetrix Genechip™ technology and Illumina BeadChips. Methylation analyses are
offered using Illumina methylation arrays and reduced representational bisulfite sequencing on Illumina HiSeq
instruments. An important additional capability is offered by the RNA Interference shared resource, which
provides special contract pricing on packaging reagents for lentiviral production and access to the complete
Open Biosystems pGIPZ knockdown library to all Mayo Clinic investigators. Each of the 4 areas of focus
(Sequencing, Gene Expression, Genotyping and RNA Interference) is directed by a senior staff-level Associate
Director with expertise in the area of focus. With significant institutional support, we have continued to add new
instruments, personnel and services in support of MCCC activities. There is a well-developed cooperative
administrative structure that oversees our activities and ensures timely access and affordable pricing to MCCC
members. All of our activities are data intensive, and we interact closely with the IT and bioinformatics
resources to meet the needs of our users, from project inception through the final delivery of data. Since the
last competitive grant renewal, more than 158 MCCC members from the 10 Programs and all 3 MCCC sites
have used the services offered by the GEN and MCCC projects account for about half of all the activity in the
GEN. The value of this resource to the MCCC is highlighted by the large number of high-quality, peer-reviewed
publications that were based upon data produced in our facilities.